Epigenetic Mechanisms Underlying Drug-seeking Behavior: Role of HDAC3 in Regulating Gene Expression within the MHb Cholinergic Population for Cocaine-induced Relapse-like Behavior

Project Summary/Abstract
As a chronic neuropsychiatric disease, addiction is associated with specific molecular and
functional neuronal plasticity changes that are triggered by repeated drug exposure leading to
persistent changes in neuronal function and ultimately behavior. One powerful mechanism that
may underlie aspects of this persistence is epigenetics. Epigenetics (i.e., modulation of gene
expression that occurs through altered chromatin structure without changes to the DNA sequence
itself) has been shown to establish stable changes in cell function. These stable changes in cell
function can give rise to remarkable changes at many levels of observation (e.g., neuronal
plasticity, behavior). Currently, we still know very little about the epigenetic mechanisms that
establish the persistence characteristic of drug-seeking behavior and whether such mechanisms
may also be involved in reinstatement, or other relapse-like behaviors. Here, we will focus on the
role of the medial habenula (MHb) in cocaine-induced reinstatement of drug-seeking behavior.
Recent studies have begun to implicate the MHb in cocaine-associated behaviors, yet the role of
the MHb in regulating reinstatement of cocaine-seeking behavior remains largely unknown. In fact,
the MHb is rarely included in reward circuitry diagrams. Our recent findings demonstrate that the
MHb is engaged by cocaine-primed reinstatement and the activity of choline acetyltransferase
(ChAT) expressing neurons in the MHb is sufficient to drive reinstatement (15). These results
suggest that the MHb is a powerful regulator of relapse-like behaviors, which has important
implications for understanding the reward pathways in the brain related to relapse. We will examine
the role of a histone deacetylase, called HDAC3 in MHb-dependent reinstatement of drug-seeking.
HDAC3 is a key negative regulator of memory formation and associative plasticity, which functions
by repressing the expression of important downstream target genes. HDAC3 is highly expressed in
the MHb within ChAT expressing neurons, indicating that HDAC3 (an pivotal regulator of memory
processes) has a central role in behaviors associated with MHb-dependent reinstatement. In this
proposal, we will test the central hypothesis that the MHb is a key regulator of reinstatement of
cocaine- seeking behavior and does so in an HDAC3-dependent manner. Successful completion of
these studies will demonstrate the key nature of the MHb in reinstatement, identify the
physiological processes in the MHb responding to cocaine, and identify key epigenetic regulators
of MHb function.

Public health relevance
Project Narrative Drugs of abuse, such as cocaine, are known to cause stable changes in neuronal function throughout the reward pathway and lead to drug-seeking and drug-taking, even following long periods of abstinence. Yet, the specific long-term molecular mechanisms that can lead to relapse remain unclear. The experiments in this proposal will examine the role of the histone modifying enzyme HDAC3 within the cholinergic population of medial habenula cells, and its role in mediating relapse cocaine-associated behaviors.